Leprosy Research Support and Maintenance of an Armadillo Colony

The Leprosy Research Support and Maintenance of an Armadillo Colony interagency agreement provides standardized research reagents to investigators worldwide to assist in the development of skin test antigens used to detect leprosy.